Undergraduate Fundamentals in Aging Research

PROJECT SUMMARY
Aging is the greatest risk factor for most chronic illnesses, and the interdisciplinary field of geroscience aims to
understand the mechanisms of biological aging that impact the development of such age-associated and
chronic diseases. While this concept has gained traction in some graduate programs affiliated with medical
schools, geroscience is not well recognized or represented at the undergraduate level. To address the need
for growing the geroscience workforce, the long-term goal of this education program is to increase the quantity
and quality of new geroscience investigators by providing teaching and training to the most foundational
population for strengthening the geroscientist pipeline – undergraduate students. NIA support will enable our
creation of an undergraduate Education in Aging and Geroscience Research (EAGR) program. It is designed
to support educational and research activities for undergraduates that will advance both basic and translational
aspects of geroscience. Our EAGR program will be implemented through the execution of 5 synergistic Aims:
(1) Create a geroscience coursework curriculum for training undergraduate students in the biological bases of
aging and fundamentals of aging research; (2) Establish a research program for undergraduate students to
gain hands-on experience in laboratories studying geroscience and the pillars/hallmarks of aging; (3) Promote
career development and scientific communication activities that expedite student admission into graduate
programs and identification of geroscience PhD labs; (4) Enhance the diversity of student researchers entering
the geroscience field; (5) Disseminate course materials and research findings to the geroscience community
and improve the public understanding of geroscience. By seeding the field of aging with new researchers and
sharing the procedural aspects of the EAGR program, we hope to impact geroscience for many years to come.

Public health relevance
PROJECT NARRATIVE Aging is the greatest risk factor for most chronic illnesses. The field of geroscience seeks to counteract the development of such diseases by understanding and manipulating the basic biological mechanisms that impact the aging process. To address the growing need for a geroscience workforce, the goal of this research education project is to increase the quality and quantity of new geroscientists entering the field by creating an Education in Aging and Geroscience Research (EAGR) program for Undergraduate students.